Longitudinal PET/MRI assessment of the pancreas in individuals at risk for and with recent onset type 1 diabetes

PROJECT SUMMARY
Over 1 million people have type 1 diabetes in the United States and greatly affects their quality of life. In vivo
measurement of insulin vesicle functional capacity (IVFC) and beta cell mass (BCM) would allow tracking and
monitoring of recent advances in therapies designed to preserve IVFC and BCM and/or monitor transplanted
beta cells. Beta cell loss occurs in the endocrine pancreas resulting in loss of insulin secretion and subsequent
onset of diabetes. Current clinical measurements of beta cell function (e.g., C-peptide release in response to
oral glucose tolerance test (OGTT)) may underrepresent total IFVC or BCM due to variability in beta cell function
in response to glucose.
The aim of this study is to utilize PET and MR techniques to study insulin vesicle functional capacity, beta cell
mass and pancreas volume in non-diabetic individuals, and stage 2 T1D with high and low PI:C ratio as they
progress to stage 3 T1D.
The opportunities afforded by this award would enable us to provide a comprehensive picture of multiple
longitudinal measures of beta cell function and mass in vivo and increase our knowledge of the relationship of
proposed imaging markers to greater pancreas architecture and function.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes negatively impacts an individual's health and quality of life, and affects a substantial burden on communities and society. The proposed research program will investigate stage 2 T1D with high and low PI:C at baseline and age-matched non-diabetics to measure insulin vesicle functional capacity, beta cell mass and pancreas volume in vivo. Longitudinal assessment of these measures will give a better understanding of the intra-subject progression of type 1 diabetes and may inform more effective treatment monitoring strategies, improving quality of life and reducing societal burden.